ANKLE TRACKING TRAINING IN STROKE

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. The overall goal of this project is to determine whether joint movement tracking training at the ankle in subjects with stroke is effective in promoting brain reorganization and recovery of function.